Mechanisms of Tetrodotoxin Synthesis in Microbial Symbionts

PROJECT SUMMARY
Tetrodotoxin (TTX) is an extremely potent neurotoxin that gives pufferfish (fugu) sushi an element of danger.
TTX derives its lethal toxicity from its ability to block the pore of almost all voltage-gated sodium channels,
preventing most neurons and muscle cells from generating action potentials. Since its initial discovery in
pufferfish, TTX has been identified in a wide array of animals, all of which appear to derive their TTX from
bacteria, either directly or through sequestration from diet. Although the structure and mechanism of action of
TTX were identified more than 50 years ago, the means by which it is synthesized in vivo are completely
unknown. The long-term goal of this project is to elucidate the mechanisms of TTX biosynthesis, enabling
development of assays for TTX, improving food safety, and facilitating the discovery of TTX analogs with
therapeutic potential. To do so, we are leveraging our discovery of TTX-producing (TTX+) bacteria on the skin
of newts that are endemic to the west coast of North America. These animals live in readily accessible
freshwater habitats and are not threatened or endangered, allowing us to collect newts easily and isolate new
strains of TTX+ bacteria. This ability is important, as previous researchers have been restricted to working with
single strains of TTX+ bacteria isolated from marine animals, limiting attempts to uncover the genetic basis of
TTX production. We plan to use three complementary approaches to discover genes involved in TTX
biosynthesis. In Specific Aim 1, we will sequence complete genomes of all TTX+ bacteria that we have
identified to date, comprising 22 strains across 7 genera. We will then analyze these genomes to identify
candidate genes that may be involved in TTX synthesis. In Specific Aim 2, we will use experimental evolution
to identify genes that are mutated, inverted, excised, or have decreased expression in strains that lose TTX
production upon repeated passaging, a proclivity that has been previously described by other groups. In
Specific Aim 3, we will use a forward genetic screen to create and identify mutants that do not produce TTX
(TTX-). As an important component of this work, we will develop a high-throughput assay for detecting TTX; we
are currently exploring two approaches, one involving MALDI-MS and the other involving a TTX-specific
aptamer. We will determine which assay is more efficient and sensitive but will employ our more standard
HILIC-MS/MS approach if both efforts fail. The genomes generated in Aim 1 will be used as a reference to
identify the genes in which mutations reduce TTX production in our genetic screens in Aims 2 and 3. In tandem
with this work we will develop protocols for genetic manipulation of our strains of interest to facilitate future
work in which we will create knockouts to validate the candidate genes identified in all three aims.

Public health relevance
NARRATIVE Tetrodotoxin (TTX), originally isolated from pufferfish, is a potent, bacterially derived toxin that is widely used in neurobiological research. We propose a set of experiments to unravel the genetic basis of TTX production. Doing so will contribute to basic research by revealing novel biochemical mechanisms and intermediate compounds that can be used in research, and will contribute to human health by improving food safety and facilitating the development of new therapeutics for use in treating some types of chronic pain.